STAFF INVESTIGATORS: AYTEKIN OTO, M.D.

Based on the previous CCSG review (2007), the recommendations of our External Advisory Committee, and our strategic planning efforts, the UCCCC has identified the expansion of basic, clinical, and translational imaging research as a high priority. To expand our imaging research and improve the clinical management of cancer, the Advanced Imaging Program (Al) has undergone significant restructuring. Specifically, a high priority has been placed on the integration of imaging and imaging analysis methodology into clinical trials to evaluate new therapies and contrast agents, as well as developing and testing new imaging methods. CCSG funds are requested to support one Staff Investigator, Dr. Aytekin Oto, to spearhead these efforts. The Staff Investigator will work closely with the Imaging Working Group, UCCCC senior leaders, and existing or developing Shared Resources, and the Department of Radiology modality-specific laboratories to facilitate translational and clinical imaging research.

Public health relevance
RELEVANCE (See instructions): Imaging plays a key role in the UCCCC's effort to offer patients state-of-the-art diagnosis and treatment for cancer. The development of 'personalized medicine', will rely heavily on non-invasive methods to assess individual risk, find early cancers, guide treatment delivery, assess therapeutic response, and evaluate and prevent adverse health outcomes. This Staff Investigator position will lead the efforts to apply imaging to cancer care through the collaborative efforts of imaging scientists and clinicians.